Health and Housing Impacts of Unsheltered Homeless Encampment Resolution Programs

PROJECT ABSTRACT
The number of people experiencing homelessness (PEH) in the U.S. has reached record levels, rising by 13%
since 2020. A growing proportion of PEH are experiencing chronic homelessness, illustrating increasing
challenges in creating effective pathways to stable housing. The short supply of affordable housing in
communities across the U.S. complicates efforts to scale evidence-based, permanent supportive housing
programs to meet the scale of the homelessness crisis. Faced with a growing population of PEH living
unsheltered in homeless encampments, many municipalities have been developing new, innovative programs
focused on “encampment resolution”. Encampment Resolution Programs (ERPs) utilize harm reduction policies
similar to housing first programs and provide a range of interim housing options. ERPs have been endorsed as
a way to quickly clear the streets and help reduce health disparities and mortality among PEH as they transition
to permanent housing. However, there is also a risk that these programs could create a revolving door, sending
PEH back to the streets and worsening health disparities by severing their connections to trusted social and
healthcare networks. Hundreds of millions of dollars have been allocated to support ERPs, yet there is limited
empirical evidence examining their effectiveness in reducing homelessness and improving health outcomes.
This proposed project will use a mixed method design to provide the first longitudinal evidence on the potential
health benefits of ERPs. The study is informed by an integrated weathering framework that links the
environmental stressors associated with unsheltered homelessness to indicators of accelerated aging. Our work
is situated in Los Angeles County, CA, which has the nation’s largest homeless population, with 75% living
unsheltered. We will recruit 400 ERP enrollees into a unique and existing longitudinal study of ~500 unsheltered
PEH known as the Periodic Assessment of Trajectories of Housing, Health and Homelessness Study, or PATHS.
Using monthly and biannual surveys, we will assess the effects of ERPs on long-term housing trajectories and
a range of health outcomes by comparing the newly recruited ERP cohort to the existing representative
comparison cohort from PATHS. Outcomes will include those related to accelerated aging, its underlying drivers,
and the social determinants of health. We will examine the overall effects of the ERP program on health, and
disaggregate the results based on whether individuals progress to permanent housing, remain in interim housing,
or return to the streets. These findings will be complemented by qualitative interviews with ERP participants
about their health and housing experiences. Based on these results, we will develop innovative housing policy
guidelines to support policymakers and practitioners in improving the health and well-being of PEH.

Public health relevance
PROJECT NARRATIVE This 5-year study will conduct a large-scale mixed-methods evaluation of Encampment Resolution Programs (ERPs), a housing intervention aimed at transitioning people experiencing homelessness (PEH) from encampments into temporary, private accommodations with supportive services. We will enroll PEH entering ERPs in Los Angeles, California into an existing longitudinal survey study of PEH, track their housing trajectories, compare their health outcomes with a representative sample of non-ERP participants, and supplement this data with qualitative interviews from ERP participants. The findings will provide critical insights into the effectiveness of ERPs in improving both housing stability and health outcomes, shaping future policies and interventions to address homelessness more effectively.